Rapid point-of-care detection of Hepatitis C viral RNA using multiplexed CRISPR/Cas platforms

PROJECT ABSTRACT/SUMMARY
In 2017, WHO estimated 71 million people had chronic Hepatitis C Virus (HCV) but 40-50% of the living
patients were unaware of their infection status. In 2016 alone, an estimated 399,000 HCV-related deaths were
reported by WHO. CDC estimates that between 2013-2016, around 2.4 million people were infected with HCV
within the US and only a fraction of them were diagnosed properly. A rapid and inexpensive detection of HCV
RNA would allow quicker intervention and can significantly reduce the risk of death and infection rate, especially
in resource-limited settings. By engineering and multiplexing CRISPR/Cas systems in unique ways ultra-
sensitive detection of low copies of HCV RNA can be achieved for blood samples within 30 minutes. This project
proposes development and clinical validation of two highly innovative CRISPR-based approaches for detecting
HCV genotype in a lateral flow assay. Type V and VI CRISPR/Cas systems when bound with their specific target
nucleic acid sequence, activate a secondary collateral nuclease activity that can rapidly cleave single-stranded
nucleic acids in a non-specific multiple turnover manner. This collateral nuclease activity has been utilized for
rapidly detecting nucleic acids. However, they have nanomolar sensitivity and require pre-amplification of a target
to achieve attomolar detection that is desirable for clinical use. While pre-amplification can be achieved by
isothermal techniques this requires additional manipulation steps and a stable temperature control increasing
the time and cost of an assay.
To eliminate the need for target pre-amplification while maintaining high sensitivity and specificity, this
high-risk/high-reward project proposes two innovative approaches to achieve rapid detection of HCV RNA
without any target amplification. For the first aim, a recently developed `CRISPR-ENHANCE' (CE) platform from
the PI's lab that achieved femtomolar detection of nucleic acids in 30 minutes without any target pre-amplification
(Nguyen et al., Nat. Comm., 2020) will be tested in a combinatorial fashion to further enhance the sensitivity for
detecting clinical levels of HCV RNA using a lateral flow assay. The second aim is to develop and clinically
validate a CRISPR Chain Reaction (CCR) based test for detecting HCV RNA and genotypes using multiplexed
lateral flow assay and quantifying RNA using a simple fluorescence-based point-of-care device. Both the
approaches will be clinically validated in banked samples with acute/chronic infections as well as longitudinally
monitor patients undergoing anti-viral therapy in collaboration with Hepatitis C Therapeutic Registry and
Research Network (HCV-TARGET), an international consortium of leading HCV investigators. All the
components as defined by the ASSURED (Affordable, Sensitive, Specific, User-friendly, Rapid and robust,
Equipment-free and Deliverable to end-users) criteria by WHO. The development of a rapid diagnostic platform
would allow quicker treatment, reduce outbreak and faster response from patients. In future, this approach would
enable detection of other genotypes of HCV and etiologic agents.

Public health relevance
PROJECT NARRATIVE Rapid detection of HCV RNA at an early stage using a lateral flow-based point-of-care device can save lives of millions of HCV-infected individuals by enabling early intervention, simplifying universal HCV screening pipeline, making it more accessible to resource-limited settings, and preventing spreading. This project defines two novel approaches to detect HCV RNA based on our engineered CRISPR/Cas12a systems coupled with a lateral flow assay. This approach will follow the ASSURED (Affordable, Sensitive, Specific, User-friendly, Rapid and robust, Equipment-free and Deliverable to end-users) criteria as recommended by the World Health Organization to make it amenable to the resource-constrained settings.